The Physiology of Vestibular Compensation

Project Summary
This research program is motivated by two goals. First, we seek to understand the neural mechanisms
by which the brain adapts to changes in vestibular (inner ear balance) input. Second, we seek to
advance development of a vestibular prosthesis/implant, a highly innovative treatment approach with
potential to improve quality of life for individuals disabled by disequilibrium and unsteady vision after loss
of vestibular sensation. In the United States alone, approximately 150,000 adults suffer disabling vertigo
and unsteadiness each year due to acute unilateral loss of vestibular function, while about 65,000 suffer
chronic imbalance and unsteady vision typical of severe bilateral sensory loss that fails to resolve despite
existing treatments.
Sudden, permanent loss of vestibular nerve input causes disequilibrium, visual blurring due to
disruption of the vestibulo-ocular reflex (VOR), and postural instability due to disruption of vestibulo-spinal
reflexes. These symptoms are usually followed by impressive but incomplete recovery. During the
previous funding period, we made excellent progress in defining the dynamics of compensation in these
vital reflexes. In addition, we established how these pathways respond acutely to activation of a
multichannel vestibular prosthesis (MVP), and have developed a primate model for single unit studies of MVP
mediated restoration of gaze/postural control and gait stability. In the proposed research, we will build upon
this solid foundation of progress through 3 synergistic aims. Experiments addressing Aim 1 will determine
how central vestibular pathways encode motion-modulated MVP stimulation and establish whether the use of
certain stimulation waveforms can enhance neural and resulting reflex responses. We predict that adaptation
of vestibular nuclei neurons is detrimental to generating prosthesis-evoked responses, and that methods to
desynchronize and increase afferent recruitment will improve functional outcomes. Aim 2 experiments will
examine mechanisms underlying the context-specific integration of prosthetic and extravestibular information
by investigating neural responses during gaze stabilizing & shifting behaviors. These experiments will extend
our investigation beyond reflex pathways and provide both systems and neuronal-level insight into how the
central nervous system (CNS) optimizes performance during complex behaviors typical of daily life.
Experiments addressing Aim 3 will examine, in freely moving monkeys, the context-specific processing of
prosthetic vestibular input at the single unit level during natural self-motion behaviors including postural control
and gait. Combined, these studies will enhance our understanding of how the CNS adapts to changes in
vestibular input; advance development of a potentially revolutionary treatment for loss of inner ear
function; and clarify how neuronal mechanisms that underlie learning at a single cell level can be
leveraged to optimize recovery of individuals disabled by loss of vestibular sensation.

Public health relevance
Narrative After loss of vestibular (inner ear balance) sensation, some patients ultimately recover enough to perform daily activities, but many fail to fully compensate and remain disabled by chronic imbalance and the inability to see clearly while moving. This research project will identify the neural mechanisms that underlie how the brain adapts to changes in vestibular input and will advance development of an implantable bionic inner ear device that can help restore quality of life to thousands of individuals disabled by unilateral and bilateral loss of vestibular sensation.